ORAL ALDOSE REDUCTASE INHIBITOR IN DIABETIC NEUROPATHY

The purpose of this study is to determine the effect of aldose reductase inhibition in patients with stable diabetes and symptomatic peripheral neuropathy.